Physical Biochemistry and Biology of Amyloid Beta-Protein

DESCRIPTION (provided by applicant): Alzheimer's disease (AD) is a devastating disease of the aged. Two amyloid-forming proteins are associated with AD, the amyloid β-protein (Aβ) and tau. Recent evidence supports an hypothesis, the "amyloid cascade hypothesis," that posits that Aβ oligomers are the seminal neuropathogenetic agents in AD. The overall goal of this proposal is to understand the structural biology of Aβ, and fragments thereof, and to establish formal structure-activity relationships. In the long run, we seek to obtain an atomic-resolution determination of the structure of the proximate neurotoxins formed by Aβ, and in doing so, enable the development, for the first time, of disease-modifying AD treatments. A multidisciplinary strategy, employing complementary experimental and computational approaches, will be employed. This strategy has been used very successfully in the past, providing novel insights into the Aβ system. Three specific aims are proposed that systematically and logically progress from in vitro biophysical studies of Aβ and its oligomeric assemblies (Aim 1), to in vitro and in vivo studies of the biological activity of selected such assemblies (Aim 2), to determination of the effects of selected assemblies on differential gene expression in neurons (Aim 3). Taken together, these studies will provide the theoretical and experimental foundation for subsequent therapeutic compound development and clinical testing in humans. Aim 1. To determine the structural dynamics of Aβ and tau assembly. a. To use scanning Tyr mutagenesis to elucidate mechanisms of Aβ oligomerization. b. To determine the dynamics of intramolecular turn formation and its effects on Aβ assembly. c. To determine the effects of primary structure changes on the conformations and assembly dynamics of biologically relevant and theoretically important Aβ peptides. Aim 2. To determine the biological effects of Aβ assemblies. a. To determine the cytotoxic effects of Aβ assemblies on cultured neuronal cell lines and primary neurons. b. To determine the effects of Aβ assemblies on Drosophila eye development, locomotion, and longevity. Aim 3. To identify and validate AD-relevant genes using a bioinformatics approach that considers Aβ assembly structure, neuron type, and neuron senescence. PUBLIC HEALTH RELEVANCE: An estimated 5.3 million suffer from Alzheimer's disease (AD) now in the United States. This number is expected to triple before 2050. If this occurs, AD will bankrupt the country, and other countries around the world. The work proposed seeks to determine the proximate neurotoxic agents in AD, and the genes that make neurons susceptible to these agents. Without this information, therapeutic agents to treat, cure, or prevent AD cannot be developed.

Public health relevance
An estimated 5.3 million suffer from Alzheimer's disease (AD) now in the United States. This number is expected to triple before 2050. If this occurs, AD will bankrupt the country, and other countries around the world. The work proposed seeks to determine the proximate neurotoxic agents in AD, and the genes that make neurons susceptible to these agents. Without this information, therapeutic agents to treat, cure, or prevent AD cannot be developed.